Adaptation to frequency-place functions in cochlear implant users

ABSTRACT This is an administrative supplement request under Funding Opportunity Announcement (FOA) Number PA-18-906. According to the FOA, the Research Strategy section “must include a summary or abstract of the funded parent award or project” and the present application does include such a summary. The FOA further indicates that “Other sections should also be included if they are being changed by the proposed supplement activities”. In the present case, the abstract is unchanged. We are including the present file (contradicting the FOA instructions) for a combination of two reasons: 1) We have been informed by the eRA Commons help desk that their system does not allow streamlined submission of 21-month supplement requests such as the present one, and 2) Grants.gov requires an abstract before the application will be processed.

Public health relevance
PROJECT NARRATIVE The human auditory brain is remarkably plastic and, given enough time, can adapt to major distortions in peripheral frequency-place maps. The overarching goal of the proposed research is to find the full extent and possible limitations of this adaptation process. The study will make extensive use of listeners with normal hearing in the unimplanted ear but the results will influence clinical practice for a wide range of postlingually deaf CI users.